COMPLIANCE WITH ASTHMA REGIMENS ACCORDING TO SES AND HEALTH BELIEF DIFFERENCES

The aims of this project are to identify the socioeconomic and demographic factors associated with noncompliance with inhaled corticosteroid regimens; to examine the difference in health beliefs among patients that lead to noncompliance; to determine whether these health beliefs differ among socioeconomic and ethnic groups. Sixty subjects have now completed the protocol and enrollment is closed. Data is being analyzed.